The thalamic paraventricular nucleus mediates the influence of early-life adversity on reward-seeking behaviors

Project Summary
This proposal centers on the role of the paraventricular nucleus of the thalamus (PVT) in mediating the
impact of early life adversity (ELA) on reward-seeking behaviors later in life. I will identify and characterize PVT
neuronal populations that are engaged by ELA, test the hypothesis that these neurons execute the enduring
effects of ELA on reward-seeking behaviors, and investigate a potential mechanism behind this process. Early
life adversity (ELA) consisting of factors such as poverty, trauma, or chaotic environment impacts the lives of
over 30% of children in the United States. ELA is associated with poor cognitive and emotional health and
increased risk for affective disorders, including depression, PTSD, and addiction, which involve aberrant reward-
circuit function. Studies in animals have demonstrated causal relations between ELA and impaired reward-
seeking behaviors and enable the establishment of underlying neurobiological mechanisms. It is crucial to
understand these associations, because ELA and its consequences, unlike genetic contributors to vulnerability
to psychopathologies, may be amenable to prevention or mitigation.
The paraventricular nucleus of the thalamus (PVT) is an important component of the reward circuit that
encodes remote emotionally-salient experiences to influence future reward-related behaviors. However, it
remains unknown if the PVT encodes experiences as remote as ELA and whether PVT neurons activated during
ELA contribute to deficits in reward-seeking behaviors later in life. Building on my robust preliminary data and a
potent validated naturalistic model of ELA in mice, which provokes deficits in reward-seeking behaviors later in
life, my central hypothesis states that PVT neuronal populations are activated during ELA and contribute to ELA-
provoked deficits in reward-seeking behaviors later in life. To test this hypothesis I will (a) capitalize on a
transgenic mouse for activity-dependent genetic labeling [Targeted Recombination in Active Populations
(TRAP2) mice] to determine the the location of neuronal populations within the PVT that are activated by ELA
and establish their molecular identity; (b) use chemogenetics to probe the role of PVT neurons activated during
ELA in governing reward behaviors later in life; (c) establish the differential PVT activation during reward-seeking
behaviors in adult ELA and control mice, with a potential role in the observed behavioral impairments. Together,
the proposed experiments will provide critical information about the developmental functions of the PVT and its
contributions to the impact of ELA on reward-seeking behaviors, significantly advancing our understanding of
the neurobiological mechanisms underlying reward-related psychopathologies.

Public health relevance
Project Narrative Many serious mental illnesses, including depression and addiction, are characterized by disruption of the ability to experience and seek out pleasure and rewards. A clear connection has been established between these mental health issues and adversity early in life, and an understanding of the mechanisms behind this connection is crucial to identifying those at risk and implementing preventative or mitigative strategies. The proposed research will examine the neurobiological mechanisms by which the paraventricular nucleus of the thalamus, an important component of the brain’s reward circuit, contributes of early life adversity-provoked disturbances in reward seeking and mental health.